Examining the interplay of complexin and synaptotagmin at the synapse

Project Summary
Research into the molecules underlying synaptic exocytosis has revolutionized our understanding of synaptic
transmission and connections to a variety of neurological and psychiatric disorders, but several fundamental
challenges remain. In particular, decades of research have yet to resolve the precise function of a critical piece
of the synaptic vesicle fusion apparatus: Complexin (CPX). CPX is a small cytoplasmic protein containing a
highly conserved SNARE-binding motif known as the central helix (CH), that is surrounded by a poorly conserved
accessory helix (AH) and a C-terminal amphipathic domain (CTD). Past studies suggest that CPX works in
tandem with the vesicle-associated protein Synaptotagmin-1 (Syt1) to prepare and maintain synaptic vesicles
(SVs) in a fusion-ready state, with all domains all playing crucial roles in CPX function. However, the precise
mechanism remains unclear. Notably, perturbations of CPX function appear to have strikingly different impact
on mammalian vs invertebrate model synapses, although few studies have directly compared CPX biochemical
and functional properties together across widely divergent species. In this proposal, we describe a systematic
and comprehensive approach to compare the proposed functions of worm and mouse CPX and its relationship
to Syt1 using a combination of complementary in vitro, ex vivo and in vivo experimental systems, and
computational modeling. Specifically, we aim to resolve whether AH domain function together with the CH and
CTD domains or acts independently to determine the specificity and efficacy of the CPX inhibitory/facilitatory
function. We compare the CTD-membrane interactions and curvature sensitivity to test the hypothesis that the
CTD properly localizes CPX on vesicle membranes where it can efficiently bind assembling SNARE proteins.
Additionally, we assess how variations in Syt1 inhibitory function influences CPX action across species. For in
vitro analysis, we will deploy single-vesicle docking/fusion assay with high time resolution and precise control
over protein identity/density. We will test worm/mouse CPX and Syt1 isoforms as well as variants/chimeras, with
the species-specific SNARE proteins. These experiments will be complemented with physiological assays in
both C. elegans and in cultured mouse neurons. We will utilize CRISPR/Cas9 gene editing and single-copy
transgenics to explore the impact of the CPX/Syt1 variants on synaptic function in C. elegans. We will conduct
correlative analysis in cultured mouse neurons by utilizing the fast fluorescent glutamate sensor iGluSnFR to
image quantal glutamate release at individual presynaptic boutons, followed by post-hoc immunocytochemistry
to correlate these release events with the expression levels of release machinery proteins. To close the loop, we
will develop mechanistic models of synaptic transmission based on experimental data, incorporating the
synergistic actions of CPX and Syt1, and test their feasibility through computational modelling. We expect this
project will offer crucial insights into the molecular mechanisms underlying the regulation of neurotransmitter
release and contribute to the development of a detailed mechanistic model.

Public health relevance
Project Narrative This project aims to establish a consensus on the functional role of Complexin at the neuronal synapse and how it is modulated by Synaptotagmins. We propose a collaborative approach that integrates in vitro functional assays, genetic/physiological synaptic analysis, and computational modeling to examine Complexin and Synaptotagmin isoforms from both mammals and invertebrates. We anticipate that our findings will provide new mechanistic insights and advance our understanding of the regulation of synaptic vesicle exocytosis.